MODE OF ACTION OF THYMUS DERIVED (T) SUPPRESSOR AND AMPLIFIER CELLS

Direct evidence was obtained to indicate that the magnitude of the antibody response of mice to bacterial (Leuconostoc) dextran B1355 is influenced in a negative and positive manner by the action of suppressor T cells (Ts) and amplifier T cells (TA), respectively. Thus, the antibody response to this well-defined antigen can be added to the growing list of other microbial polysaccharide antigens, e.g., Type Ill pneumococcal polysaccharide (SSS-III), Neisseria meningitidis group A and C capsular polysaccharides, Pseudomonas aeruginosa lipopolysaccharide, Streptococcus mutans polysaccharide, and Serratia marcesans lipopolysaccharide, whose antibody responses are known to be influenced by regulatory T cells (Ts and TA). Evidence was obtained to indicate that populations of these regulatory T cells expand in a clonal manner in response to immune B cells and that such expansion is facilitated by IL-2.